Functional Understanding of Chromosome Arm Aneuploidies

Project Summary
Aneuploidy (gain or loss of a chromosome) and partial aneuploidy (gain or loss of a chromosome arm)
have long been observed in cancer cells and are the cause of several congenital diseases. Interestingly,
advances in next-generation sequencing have more recently demonstrated the presence of aneuploidy in healthy
cells. The goal of this research proposal is to uncover the downstream effects of individual aneuploidies.
We developed new computational algorithms to identify aneuploidy events from genomic and
transcriptomic data. Our methods allow for identification of small populations of aneuploid cells from bulk
sequencing data. In addition, single-cell sequencing of healthy tissues will allow for identification of even rarer
aneuploidy events. By leveraging existing comprehensive efforts to characterize single cells from across the
human body, we will build an atlas of aneuploidy events occurring in healthy tissue.
To directly test the effects of aneuploidy alterations in human cells, I developed a genome engineering
approach for targeted deletion of chromosome arms in vitro. We previously used this approach to generate
isogenic cell line pairs with and without chr3p deletion and found that chr3p deletion leads to cell cycle arrest.
Some of our cell lines adapted to chr3p deletion by duplicating their wildtype copy of chr3, transitioning to a state
of chr3q gain. Cells with chr3q gain showed differential dependency on genes involved in DNA replication. Here,
we will use these cells to identify the mechanisms of these cell cycle phenotypes, as well as determine which
chr3 genes contribute to these phenotypes. In addition, we will create a library of cell lines for each chromosome
arm deletion. These cell lines will be critical to compare and contrast the downstream effects of different
aneuploidy events in human cells. With this work, we will firmly establish a research program dedicated to
understanding the consequences of specific aneuploidies in human cells.

Public health relevance
Project Narrative An outstanding question in genetics and cell biology is the implication of individual changes in chromosome number (aneuploidy). We will identify patterns of aneuploidy in healthy human cells and study its downstream effects using recently developed computational and genome engineering approaches. This research will advance our knowledge of the consequences of aneuploidy.